Faraday, a Novel Automated Peritoneal Dialysis Device with Dialysate Customization

PROJECT SUMMARY
Up to 80% of the over 326,000 patients on peritoneal dialysis (PD) around the globe have hypertension and 56%
will die due to cardiovascular issues. Clinical outcomes are dictated largely by the dextrose and sodium
concentrations used in each treatment. However, the flexibility of APD systems is woefully deficient. While the
benefits of limiting glucose exposure to extend the life of the peritoneum are known, no APD device allows
users to deliver a gradually decreasing dextrose concentration. Recent evidence shows that hypertensive PD
patients could benefit from a currently unavailable reduced dialysate sodium admixture to remove excess
sodium from the blood and improve blood pressure. The recently announced Advanced American Kidney
Health Initiative (AAKHI) calls for 80% of new ESRD patients in 2025 to receive home dialysis or a transplant,
which will result in an increase from 10% to ~50% of dialysis patients using PD.
Our innovative Faraday™ APD technology created in a Phase I SBIR project enables admixing PD therapies
that remove excess sodium in the bloodstream while minimizing dextrose exposure. We have developed a
benchtop APD pumping engine prototype that accurately admixes custom solutions from five input fluids via a
proprietary cassette and pneumatics. Our Phase II development will culminate in a fully functioning,
commercializable, user-friendly APD device and tap water filtration system with custom therapies designed to
drastically reduce cardiovascular deaths and early PD technique failure.
Specific Aim 1: Develop regulatory pathway with FDA: Our goal is to develop design history file documents
and meet with the FDA in a pre-sub meeting to ensure they agree with our predicate device, water sterilization
requirements, product architecture, high-level risk mitigations, and safety systems.
Specific Aim 2: Optimize current pumping engine:. The cassette and pneumatics manifold will be
miniaturized, and a cassette-to-hardware door interface mechanism will be developed. Flow rate testing will
confirm flow rates >190 ml/min Fill and >125 ml/min Drain with the optimized pumping engine.
Specific Aim 3: Integrate pumping engine into fully functioning APD cycler: All hardware elements will be
optimized in a table-top sized portable enclosure to create a device that admixes at 1.5% accuracy. We will
develop a best-in-class UI with setup animations and intuitive therapy programming and operation.
Specific Aim 4: Develop water purification system: We will design and build a water filtration and sterilization
system to create injection-quality water to meet FDA requirements for sterility of TVC <0.1 CFU/ml, endotoxins
<0.1 EU/ml (95% confidence), and chemical contaminants per ISO 23500 and USP <1231>.
Our Phase II development will culminate in a commercializable, user-friendly tabletop APD device with sodium
and dextrose tailoring APD therapies designed to reduce cardiovascular deaths and early PD technique failure.

Public health relevance
PROJECT NARRATIVE Peritoneal dialysis devices and solutions have changed very little in the past 25 years. In this Phase II SBIR project, Simergent proposes the continued development of Faraday, an automated peritoneal dialysis device based on our Phase I prototype, which is capable of admixing its own dialysate solution from purified tap water and allowing the nephrologist to customize the sodium and dextrose concentrations to meet the patient's clinical needs. If widely distributed, ultimately the product could dramatically improve the cardiovascular outcomes of peritoneal dialysis patients by removing excess sodium from hypertensive patients and reducing excess dextrose exposure, which is harmful to the peritoneal membrane.